Supplement for CSULB Maximizing Access to Research Careers (MARC) UNDERGRADUATE STUDENT TRAINING IN ACADEMIC RESEARCH (U-STAR)

SUMMARY
CSULB MARC Undergraduate Student Training in Academic Research (U*STAR) Program
The current proposal is a Supplement to the existing parent award, California State University Long Beach
(CSULB) Maximizing Access to Research Careers (MARC) Undergraduate Student Training in Academic
Research (U*STAR) Program (NIH T34 GM008074) (06/01/2017-05/31/2022). The overall scope and
objectives of the supplement are aligned with those of the parent award with a goal to continue to increase the
number of under-served students entering and earning doctorates in biomedical sciences. The parent award
supports 10 MARC Scholars who receive enhanced academic and research training for 2 years to prepare
them to enter and succeed in graduate programs in biomedical and behavioral research areas.
At the end of the current cycle (05/31/2022), five MARC Scholars are expected to continue their second year of
training for which additional funding is needed ($ 231,813). As of 05/31/2022, the unobligated balance is
estimated to be $ 85,698. The current proposal seeks supplemental funding ($146,115) that will be used in
conjunction with the unobligated balance to successfully continue the program operation and complete the
training process of the five students (Avalos, Chen, Nguyen, Phan and Skorka), who are already listed in the
eRA Commons X-Train system. The funds will be used to support the 5 trainees’ stipend and partial tuition,
research supplies, travel to conferences and off-campus summer research experience in a research-intensive
environment, in addition to providing partial salary support for the program personnel. The goal is to continue
offering deeper and specific research training that will develop the technical, operational and professional
skills, with a focus on strengthening the trainees’ quantitative abilities in existing courses and research training
activities as described in the objectives of the parent award below. The 5 students are on track to graduate in
May 2023 and are currently engaged in faculty-mentored research projects in which they are showing strong
progress; in addition, they are preparing to apply for their off-campus research experience for summer 2022.
All components of the one-year training supported by the supplement will be evaluated like the parent program.
The objectives of the training program that will be supported by the supplement are to: (i) offer a rich, intense
education experience through research-based, Honors curriculum, supplementary academic support, priority
registration and counseling to the trainees to; (ii) provide an enriching research experience, in a mentored
environment that fosters critical thinking; in addition, the Scholars will be required to participate in a short-term
research experience in summer 2022 in a research-intensive institute; (iii) train MARC Scholars in professional
and leadership development activities, and, (iv) encourage graduate school preparation. Taken together, the
supplement will help in completing the training of the Scholars and lay the essential groundwork required for
them to enter and face the rigors of graduate school education in a highly competitive atmosphere.
Further, to continue offering research training opportunities after the current MARC T34 program has ended,
the institute leadership (Dean and Associate Dean for Research of the College of Natural Sciences and
Mathematics, and program directors of current CSULB MARC and RISE programs) has developed a strategic
plan following consultation with the NIGMS Program Officers in spring 2021. It involves submission of a new
NIGMS Undergraduate Research Training Initiative for Student Enhancement (U-RISE) (T34) in May 2022
(CSULB is eligible to apply for U-RISE based on its status as a research-active institute). The U-RISE
leadership team has been identified and involves key personnel from current T34 MARC program. The plan is
to request 30 spots for training undergraduate students from a diverse background with a proposed start date
of 06/01/2023 if funded. The trainees will receive an enriching academic and research experience for two
years, which will prepare them for graduate programs. They will carry out their research with faculty members
from diverse backgrounds, disciplines and career stages. At the same time, we would request ending the
ongoing RISE program (04/01/2020-03/31/2025) (with 20 funded spots) earlier than its projected end date (in
consultation with NIH Program officials) so that there is no overlap with U-RISE. This will ensure continuous
availability of research training opportunities for CSULB students.
In summary, the supplement to the parent award is a critical requirement to complete the training of the
five MARC Scholars. It is expected to have a lasting impact on their career decisions and entry into graduate
programs in the biomedical field.

Public health relevance
The goal of the CSULB MARC U-STAR Supplement Program is to increase diversity in biomedical research by providing enhanced academic and research training opportunities, and workshops on professional/leadership skills to underrepresented (UR) students. The objective is to increase the number of UR students entering graduate programs and earning doctoral degrees.